Development of a psycho-social transition program and transition assessment tools for Veterans with mental illness and/or substance use disorders leaving prison

45,000-50,000 veterans are released annually from state and federal prisons. These Veterans encounter a
number of severe negative outcomes following release including homelessness, inpatient psychiatric care,
unemployment, divorce, inpatient substance treatment, and reincarceration. There are a number of limitations
related to effectively serving these individuals, the primary ones being the limited number of programs
available specifically for Veterans leaving incarceration and few assessment tools to assess needs and
barriers to successful integration. To develop novel and targeted treatments and assessment tools it is
important that we understand the lived experience of those leaving incarceration. This study, conducted in
three phases, will develop the tools to assist and assess Veterans’ transition from incarceration with the goal of
improving psychosocial outcomes. Phase 1 will be a qualitative analysis of the lived experience of Veterans
leaving incarceration using identity theory and an established transition model to conceptualize the transition.
Targets will be the experience of transition, barriers and impediments to VA care, perceived needs of those
leaving prison, and behaviors that interfere with transition. It is estimated that approximately 30 Veterans will
be needed. Phase 2 will use the findings from Phase 1 and a Clinician Counselor Advisory Council to develop
a rehabilitation program and assessment tools. The rehabilitation program will be divided into modules focused
around facilitating the successful transition from prison. Assessment tools will be for assessing the phases-of-
transition, stigma, and interfering behaviors. Items will be developed by the CCAC and the meanings of the
items will be confirmed using a sample of 30 Veterans. After items are finalized, understandablity of items will
be confirmed with 20 Veterans. The psychometric properties of the assessment tools will then be determined
using a sample of 200 Veterans, with subsequent refining. The tools will be piloted on an additional 51
Veterans. Phase 3 will be a pilot intervention using the developed psychosocial rehabilitation tools. Using a
cross over design, 30 veterans will receive 8 weeks of no services followed by 8 weeks of the transition
intervention. 30 will receive 8 weeks of the transition intervention followed by 8 weeks of no intervention.
Outcomes will be, in part, the opinion of the system, willingness to recommend the system, and engagement of
the system.

Public health relevance
This study is relevant to VHA broadly due to its focus on vulnerable populations and Rehabilitation Research and Development specifically as it focuses on social reintegration. It targets an underserved population which has been identified by VA as requiring specialized services, i.e. Veterans leaving incarceration, specifically with mental illness and/or substance use disorders. This goals and methods of this application are very novel as there have been no qualitative assessment of the lived experience of Veterans leaving prison which focus upon information critical to the development of rehabilitation techniques and assessment tools. The development of rehabilitation techniques for addressing critical domains (e.g. homelessness, employment, social and family concerns, etc.) and accompanying assessment tools will be the first of their kind and will have broad utility throughout the VA for clinicians serving formerly incarcerated Veterans.